Closing the Adolescent and Young Adult Clinical Trial Enrollment Gap with an AYA (Alert, Young Adult Navigation and Alliance) Clinical Tool

Project Summary
More than 80,000 adolescents and young adults (AYAs, ages 15- 39 years) are diagnosed annually with
cancer in the United States, but relatively few enroll on cancer clinical trials (CCTs). Limited AYA participation
on CCTs hinders the ability to further improve AYA cancer care and outcomes. Initiatives to increase AYA CCT
enrollment is urgently needed. This proposal identifies several areas for improvement that are immediately
addressable and shareable within the Sidney Kimmel Comprehensive Cancer Center (SKCCC), other medical
centers, and NCI consortium groups. The approach will significantly improve AYA clinical trial participation at
SKCCC by further developing and implementing a clinical trial tool we abbreviate AYA: Alert, Young Adult
Navigation, Alliance, initially within the hematologic malignancies (HM)/pediatric BMT program and then
beyond. These interventions will cross fertilize collaboration at three levels: 1) Patient; 2) Multi-disciplinary
Provider and 3) Center/Systems. The solutions proposed will improve AYA access to and enrollment on CCTs,
strengthen the clinical research enterprise, and address cancer disparities – all NCI priorities. This proposal will
utilize a new multi-faceted alert system that includes an electronic medical record (EMR) alert to identify AYA
patients and the potential clinical trials for which they are eligible. Weekly clinical trial research meetings will
alert the multi-disciplinary team to the AYA clinical trial priority list. Patient alerts via our EMR directly linked to
the patient’s mobile device will highlight CCT enrollment and upcoming appointments. Automating the
identification of trial eligible AYA patients, providing timely information to the study team and physicians, and
keeping AYA patients engaged through EMR directed mobile phone messaging will optimize enrollment and
compliance. A dedicated clinical research nurse young adult navigator will interact early with AYA patients,
help with AYA CCT enrollment, and bridge the knowledge and workflow gap between our adult and pediatric
consortium trials. A cohort of prior AYA CCT participant survivor navigators will serve as spokespeople on our
AYA website and on social media. An AYA psychosocial navigator will round out the partnership to improve
AYA support. Lastly, a multi-faceted education campaign will be launched to improve alliances. NCI-
consortium enrollment issues will be highlighted at joint HM/pediatric BMT clinical research meetings. We will
create cross-network enrollment FAQ documents. Using digital communication, we will provide information to
AYAs about CCTs to supplement discussions with providers. We will extend the ongoing projects initiated by
the Diversity and Inclusion in Clinical Research Program at SKCCC to include an AYA patient focus to optimize
the enrollment of underserved minorities. Best practices identified from this project will be readily transferrable
to the entire SKCCC enterprise and other academic medical centers. As a nationally recognized BMT expert
with a strong commitment to NCI-funded clinical trials and extensive knowledge in clinical research operations,
Dr. Symons is poised to lead these efforts and successfully enhance AYA accruals.

Public health relevance
Project Narrative This research proposal addresses patient-, provider, and system- level barriers in accruing adolescent and young adult (AYA) patients (ages 15-39y) to cancer clinical trials (CCTs).The major goals of this project are to further develop and implement an AYA (Alert, Young Adult Navigation, Alliance) toolkit to streamline operations, bridge the gap between pediatric and adult consortium clinical trials, and improve AYA enrollment and retention. Protected effort for the duration of the award will provide Dr. Symons with the necessary time to develop and implement the metrics and meet regularly with all of the stakeholders involved in these endeavors.